Program Development Pilot Core

Project Summary
The overarching goal of the Program Development Pilot Project Core (Core B) of the Michigan Center on the
Demography of Aging (MiCDA) is to enhance knowledge creation related to MiCDA’s signature themes, by
developing and mentoring a new national cohort of emerging scholars. MiCDA’s focus over the next cycle will
emphasize two overarching thematic areas: the changing demography of late-life disability, dementia and family
caregiving; and the social, environmental and biological underpinnings over the life course that shape later-life
health and wellbeing. A third theme, cross-cuts the two substantive foci, by advancing data infrastructure and
methods to promote breakthroughs in the demography of aging. In the coming cycle, Core B will advance these
areas of research, with attention to the disproportionate distribution of late-life health in the US population, by
undertaking activities that will engage scholars across disciplines, career stages and institutions. Specifically,
Core B will provide pilot funds to a new national cohort of emerging scholars and develop and implement an
accompanying mentoring curriculum. MiCDA pilot recipients will receive one-on-one mentorship from an
experienced MiCDA affiliate and will participate, with emerging scholars who are pilot recipients from any
National Institute on Aging (NIA) Demography & Economics of Aging Center nationally and early career MiCDA
affiliates, in seminars focused on manuscript preparation and grant proposal development. In addition, through
Core C, MiCDA pilot recipients and early career MiCDA affiliates will receive training in science communication
and amplification of research findings to scientific and lay audiences. Core B will also collaborate with Core A on
tracking, analyzing and reporting outcomes.